ACUTE RADIATION-INDUCED LUNG INJURY IN THE RHESUS MACAQUE AND ITS' TREATMENT BYIPW-5371, A SMALL MOLECULE INHIBITOR OF TGF# RECEPTOR-1 KINASE

1. This contract supports the development of safe and effective MCMs to mitigate and/or treat tissue injuries arising from exposure to ionizing radiation from a radiological or nuclear incident, thereby leading to a reduction in radiation-associated morbidities and mortalities.